A comprehensive study of sequence variation effects on PCNA function.

Project Summary
Mutations in genes encoding proteins that are essential for cell processes such as DNA replication can lead to
cellular dysfunction and disease. Protein defects can perturb these cell processes by removing or surpassing
cell cycle checkpoints, leading to errant growth and proliferation of cells, defining characteristics of cancer. As
such, it is essential to investigate Proliferating Cell Nuclear Antigen (PCNA), the central player that coordinates
DNA replication, DNA repair, and cell-cycle regulation. PCNA, also known as the sliding clamp, is a homotrimeric
ring that slides along DNA to facilitate interactions of over 100 known proteins, many involved in cancer
development and other important cellular processes. The sliding clamp is conserved across all life forms,
providing insight into the evolution of DNA replication and cell-cycle machinery. Thus, PCNA is an ideal target to
investigate mutational effects on protein function and the long-term impacts on the cell.
In Aim 1, we will address an interesting paradox related to PCNA. Point mutations in PCNA that result in subtle
biochemical effects cause severe disruption of organism fitness, suggesting that PCNA is especially sensitive to
mutations. Conversely, PCNA genes across evolution are widely varying in sequence suggesting that PCNA is
actually accepting of mutations. To investigate this contradiction, we will perform a mutational scan of all potential
point mutations in the yeast PCNA protein. These mutants will then be exposed to DNA-damaging agents to
assess the effects of the PCNA mutants on various PCNA functions. I predict that a mutational screen of PCNA
will show mutational effects on cell viability and DNA damage response based on residue location in PCNA
providing insight into the acceptability of point mutations in PCNA. This data will also provide insights into
potential disease mutations that could impact human PCNA. The Kelch lab has previously investigated two
disease-associated germline mutations in PCNA. These mutations lead to PCNA-associated DNA repair disorder
(PARD), characterized by UV sensitivity, neurodegeneration, premature aging, and, most notably, the
development of skin cancer.
In Aim 2, we will investigate how patient-associated mutations in PCNA affect biochemical and cellular function.
I selected variants based on association with cancer or PARD. I will establish mutant human retinal pigment
epithelial (RPE1) cell lines using CRISPR/Cas9 techniques. Once these cell lines are established, I will assess
the cellular impacts by using flow cytometry and DNA-damage assays. I will compare these results with tests of
the biochemical functions using isothermal titration calorimetry and thermal shift assays. I predict that the
mutations will exhibit defects in thermostability, cell regulation, and DNA repair. The impact of this study is two-
fold. First, the study will enhance our understanding of how PCNA function and evolution are intertwined. Second,
the study will investigate select human PCNA mutants that can inform cancer diagnosis and provide a framework
for investigating other proteins.

Public health relevance
Project Narrative: Proliferating Cell Nuclear Antigen, PCNA, is an essential protein involved in maintaining genome integrity, cell growth, and cell reproduction. Genetic mutations in PCNA have been associated with detrimental diseases, including a predisposition to skin cancer. Thus, in this study, we will be investigating the impact of mutations on the biochemical functions of PCNA with the potential to inform preventive care and therapeutic development.